NEW APPROACHES TO BRAIN TUMOR THERAPY CNS CONSORTIUM

The primary long-term objective of this proposal is to improve the therapeutic outcome for adults with primary brain tumors. This will be accomplished by participating in Phase I and II clinical evaluations of promising new agents, biologic approaches, and routes of administration in the treatment of primary malignancies of the central nervous system through the CNS Consortium titled "NEW APPROACHES TO BRAIN TUMOR THERAPY (NABTT)." This consortium is specifically designed to combine and focus the experience, resources, and capabilities of seven outstanding medical institutions (Brown University, Columbia University, The Cleveland Clinic, The Johns Hopkins University, The Massachusetts General Hospital, Northwestern University, and the University of Pennsylvania) to bear on primary brain tumors. To meet this objective, the consortium will rely on the special strengths and abilities that rest within each participating institution and within the consortium as a whole. The Johns Hopkins Medical Institutions have (1) a large number of adult patients with primary brain tumors, (2) an expert multidisciplinary clinical team in place to care for these patients, (3) extensive clinical and laboratory resources, (4) a striking number of ongoing high quality, clinically relevant, peer-reviewed and oncology, pharmacology, new drug development, Phase I and II clinical trials, neurosurgery, and neuropathology (6) extensive expertise in statistic, data management, and the coordination of multi-institutional studies, and (7) an exceptional reputation for excellence in clinical care and research. The consortium adds to these strengths as evidenced by its thorough constitution which defines its organizational structure and its emphasis on research design, protocol development, quality control, study monitoring, and data management and analysis. The secondary long-term objective of this proposal is to utilize this consortium to share human brain tumor specimens as well as other clinical and laboratory data to conduct additional research pertaining to (1) the basic biology of primary brain tumors, (2) the neuropharmacology of new therapies for primary brain tumors, and (3) improving the care and quality of life adults with primary brain tumors. The strengths of the individual institutions and consortium outlined above will allow this objectives to be reached.